Role of cell-to-cell transmission in alphavirus infection and disease

PROJECT SUMMARY
Alphaviruses include important and emerging human pathogens such as the arthritogenic alphaviruses
chikungunya virus (CHIKV) and Mayaro virus (MAYV). These viruses are disseminated by mosquito vectors
and cause acute febrile illness with severe joint pain that can progress to chronic polyarthritis. It is unclear if
chronic disease results from persistent virus infection of joint tissues and/or from host inflammatory responses.
CHIKV has emerged over the last 15 years to cause millions of human infections world-wide, resulting in
severe long-term health and economic consequences.
Our recent collaborative work demonstrated that CHIKV infection induces the formation of intercellular
long extensions (ILE) that reach from the infected cell to neighboring cells. These stable non-continuous
connections mediate CHIKV cell-to-cell (CC) transmission, a mode of infection that is resistant to high
concentrations of neutralizing antibodies (Abs) both in vitro and in vivo. We also showed that ILE formation and
CC transmission can be blocked by distinct monoclonal Abs (mAbs) to the viral envelope proteins.
This proposal is a collaborative effort by the Kielian and Morrison groups to define the viral envelope
targets for Ab-mediated inhibition of CC spread, the cell types infected by CC spread, and the importance of
this pathway in alphavirus infection and disease.
The specific aims are:
1. Determine mechanisms by which Abs block alphavirus CC spread. We will use a panel of mAbs to
define the envelope protein domains that are targeted to inhibit CC spread. Serum samples from CHIKV
patients will be tested for inhibition of CC spread, and results correlated with known disease progression and
envelope protein targets. We will also determine if MAYV infection induces ILE and CC spread, and if CHIKV
and MAYV can use this pathway in mosquito cells.
2. Elucidate the contribution of CC spread to CHIKV cellular tropism, dissemination and disease, and
viral persistence in vivo. Using our mouse models of infection, we will employ defined mAbs that do or do not
inhibit CC spread to determine the stromal and hematopoietic cells that are infected by this pathway. Using
Rag1-/- mice that lack endogenous Ab we will determine if Ab-mediated inhibition of CC spread is required to
limit viral dissemination and/or persistent CHIKV infection. We will use highly susceptible Ifnar1-/- mice to
determine if mAb inhibition of CC spread can block disease development.
The results of our studies will provide fundamental information on alphavirus CC transmission, and can
help to develop more effective Ab-based therapies and vaccines against alphavirus-induced disease.

Public health relevance
PROJECT NARRATIVE Using molecular, immunological, and in vivo approaches, this project will define roles for viral cell-to-cell transmission in alphavirus infection and disease, and elucidate how antibodies block this unique mode of viral spread. The knowledge gained from these studies could be used to develop more effective antibody-based therapies and vaccines against alphavirus-induced disease.